Preclinical Assessment of Phage Therapy for Pathogen Decolonization

Objectives include: 1) Develop animal models for studying the use of bacteriophage therapy to decolonize or treat MRSA and VRE; and 2) Identify characteristics of phage-bacterial interactions that can drive rational design of bacteriophage cocktails.